The cell-specific neurodegenerative potential of mitochondria post-traumatic brain injury

Project Summary/Abstract
This project responds to PAR-24-022 for the Trailblazer Award for new and early-stage investigators. It will test
the hypothesis that injury-induced cell-specific dysregulation in mitochondria bioenergetic and metabolic
functions transforms them into neurodegenerative factories that control the onset of acute neuroinflammation,
neuronal damage, and the AD-like pathology spread in the long term. Traumatic Brain Injury (TBI) launches a
complex cascade of poorly understood neurochemical and neurometabolic abnormalities that lead to long-lasting
disabilities and morbidity 1-4. These secondary injury effects are potentially preventable and manifest in energy
failure, metabolic dysregulation, chronic glial neuroinflammation, and death of the surrounding tissue 5-7, and
recently, researchers implicated TBI as a risk factor for several neurodegenerative disorders, such as
Alzheimer’s (AD) 5-8, Parkinson’s disorders (PD) 9,10, or Chronic Traumatic Encephalopathy (CTE) 9 later in life.
The devastating long-term consequences of brain injuries urge the scientific community to understand complex
intercellular, organellar, and molecular interactions and their contribution to injury progression if we want to
succeed in the effective development of diagnostic biomarkers and treatments for TBI patients. Based on the
extensive analysis of existing human data and some preliminary experiments from our group, where we observed
alterations in the metabolism based on the transcriptomic analysis, secreted metabolites, and miRNA 22-24,35, we
postulated that disruption in mitochondrial function is one potential regulator of injury-induced AD-like phenotype
progression 8, 9,10. Thus, this project aims to study the cell-specific mitochondria dysfunction hypothesis using a
novel approach to studying brain injury and injury-induced AD-like neurodegeneration progression by going from
human-based data collection to hypothesis testing in a human in vitro model with genetically inserted fluorescent
tags to mitochondria. We will combine neurobiology with neurometabolism to determine in Aim 1) injury-induced
intracellular and extracellular mitochondria alterations and validate in Aim 2) the molecular mechanism
associated with injury-induced cell-specific mitochondria reuptake. We anticipate building a comprehensive
understanding of spatial-temporal changes in mitochondria bioenergetic and metabolic functions after injury and
the molecular mechanisms involved in injury-induced AD-like neurodegeneration progression associated with
intercellular transfer of dysfunctional mitochondria. This proposal encompasses a novel combination of molecular
engineering, genetic, and molecular approaches to provide a comprehensive mechanistic understanding of the
response to brain-like tissue injury over a prolonged period with high spatiotemporal resolution. This would help
develop criteria for risk assessment and allow for more accurate sensing of neuropathologic damage in TBI
patients.

Public health relevance
Project Narrative Based on extensive human brain injury data research (athletes, soldiers, and non-sport related brain impacts), we hypothesized that injury-induced cell-specific dysregulation in mitochondria bioenergetic and metabolic functions transforms them into neurodegenerative factories that control the onset of acute neuroinflammation and neuronal damage and the widespread long-AD- like pathology. We will use novel genetically engineered brain cells with fluorescent mitochondria to determine cell-specific injury-induced alterations in mitochondria function and potential molecular mechanisms responsible for AD-like degeneration spread through dysfunctional mitochondrial uptake by neighboring cells over time. The outcome of this project will provide 1) a chronologic understanding of cell-specific mitochondria alterations in acute and chronic phases of brain injury progression, 2) potential molecular mechanisms that drive mitochondria alterations and further neurodegeneration progression, 3) a causal understanding of the cell-specific contribution to mitochondrial dysfunction-driven AD-like neurodegeneration progression.